AD HOC CONSULTING AND OPINIONS FOR REGULATORY RELATED SERVICES

The objective of the associated Purchase Order is to obtain pre-clinical and/or clinical regulatory consulting services for a range of product development considerations (including multipurpose prevention technologies - contraceptives with anti infective properties) supported by NICHD’s Contraception Research Branch. These services shall provide expert consultation to NICHD staff on pre-clinical, ethical, policy, and regulatory issues related to NICHD’s extramural contraceptive research portfolio and other related product development related areas, as directed by NICHD staff.